Animal Behavior Core

PROJECT SUMMARY – ANIMAL BEHAVIOR CORE
The Animal Behavior Core (ABC) provides an infrastructure for investigators to perform the most
advanced and innovative functional assessments in rodent models to assist in understanding the origins and
treatment of intellectual and developmental disabilities (IDD). The ABC supports efforts aimed at developing
and characterizing novel rodent models of IDD that result from gene identification or gene modification research
or environmental exposure studies performed by IDDRC Research Affiliates. Furthermore, the ABC is critical as
IDDRC investigators evaluate the functional outcomes of intrinsic (gene-based) and/or extrinsic (surgical,
environmental, chemical, or drug-based) interventions. Specific Aims of the ABC are: 1. Provide scientific,
management, and budgeting services to Research Affiliates using animal models for studies of IDD;
2. Provide behavioral testing equipment, research space, and novel testing protocols for investigators that
enable state-of-the-art assessment of behavior in rodent models of IDD; 3. Train Research Affiliates and their
staff in appropriate testing protocols; 4. Coordinate services across other IDDRC Cores and support
development of clinical applications; and 5. Promote the development of additional innovative techniques that
can be utilized in conjunction with assessments of behavioral functions in rodent models of IDD.